High throughput biosynthesis of ribosomally synthesized and post-translationally modified peptide natural products

Chemicals produced by living systems, or natural products, have had a tremendous impact on human health.
For example, nearly one third of all small molecule drugs approved by a regulatory agency over the past nearly
four decades have been natural products or derivatives of natural products, including over 70% of antibiotics and
40% of anticancer drugs [1]. While very useful molecules have been identified among the hundreds of thousands
of natural products that have been characterized to date, genome sequencing efforts over the past decade and
a half have revealed that we have only characterized the products of a small fraction of the biosynthetic pathways
that exist in nature. The products of these pathways have the potential to greatly impact the diagnosis and
treatment of disease, and it is critical that we develop new approaches to accelerate the identification and
characterization of new natural products and natural product-like compounds.
Towards this critical need, my group focuses on the ribosomally synthesized and post-translationally modified
peptide (RiPP) class of natural products [2], and the enzymes involved in their biosynthesis. Unique among
natural product biosynthetic pathways, the substrate of the RiPP biosynthetic enzymes is a genetically encoded
precursor peptide. This feature of the substrates allows for deep mutational analysis, not just of the enzymes,
but of their substrates as well. We will develop a platform for high throughput examination of the substrate
selectivity and activity of RiPP biosynthetic enzymes based on yeast or bacterial surface display, fluorescence
activated cell sorting, and next generation sequencing. Using this platform and gene libraries encoding substrate
variants we will study the substrate scope of these enzymes, and how that scope relates to the sequence of the
native substrate of the enzymes. Additionally, we will perform deep mutational analysis of the enzymes to identify
contributions to substrate recognition and selectivity. These studies will provide us with a deeper understanding
of how these enzymes function. With this deeper understanding, we will be able to use these enzymes as tools
to generate large libraries of natural product-like compounds that can be screened to identify those with useful
biological activities more efficiently than current natural product discovery approaches.

Public health relevance
Project narrative Chemicals produced by living organisms, or natural products, serve as the basis for a large number of pharmaceuticals on the market today. As genome sequencing has become more accessible, it has become apparent that the number of natural products that have been characterized is dwarfed by the number of biological pathways that exist in nature that can produce them, suggesting there are many more compounds to be discovered. To efficiently explore the compounds that could be produced by some of these pathways we are studying the enzymes that biosynthesize a class of natural products, and through these studies will develop an approach to produce millions of natural product-like compounds and test them for biological activity useful for the treatment of disease.